Quantifying sex-specific differences during zebrafish fin regeneration

Summary
The zebrafish regenerating fin is an important model system to understand mechanisms underlying
regeneration, skeletal development, and skeletal disease. Although overt phenotypic sex-differences during fin
regeneration have not been observed, not all sexually dimorphic traits are evident. Thus, the possibility that
there are measurable sex-differences cannot be ruled out. Indeed, one rationale for the 2016 NIH policy to
consider sex as a biological variable (SABV) was that important biological information could be missing from
studies that relied on a single sex, or that ignored sex when reporting cell/animal data. Importantly, while the
inclusion of both sexes is appropriate under the SABV policy, this may not be sufficient over the long-term to
reveal the complete biology underlying regeneration. Therefore, the long-term goal of this project is to improve
the consideration of SABV for research involving fin regeneration. The overall objectives for this proposal are
to collect, analyze, and report, phenotypic and transcriptomic data by sex during fin regeneration. The central
hypothesis is that while the majority of experimental studies during zebrafish regeneration includes both sexes,
without collecting/analyzing data separately, relevant sex-dependent differences may be lost. The rationale is
that completion of this project will reveal both sex-dependent and sex-independent outcomes. In turn, these
data will better inform future research by identifying specific characteristics of fin regeneration better served by
collecting/analyzing/reporting data by sex. The overall objectives will be achieved using two specific aims. The
goal of Aim 1 is to reveal sex-dependent phenotypes during fin regeneration. Fins at different stages of
regeneration will be analyzed for differences in commonly measured parameters including total regenerate
length, fin ray regenerate length, segment length, and cell proliferation. The goal of Aim 2 is to reveal sex-
dependent differential gene expression during fin regeneration. Fins at different stages of regeneration will be
analyzed to identify all differentially expressed genes. This proposal is innovative because completion will
generate resources that will facilitate the improved application of SABV during fin regeneration research. This
proposal is significant because these resources will drive better informed decisions about
collecting/analyzing/reporting data based on sex, and will therefore positively impact future experimental
design.

Public health relevance
Narrative The zebrafish regenerating fin is an important model system to understand mechanisms underlying regeneration, skeletal development, and skeletal disease. However, there is limited knowledge about sex- differences during fin regeneration. Because sexually dimorphic traits may not be evident, the goal of this proposal is to quantitate regeneration phenotypes and differential gene expression during fin regeneration, based on sex.